Investigating the regulatory impact of the small regulatory RNA BecO on essential virulence factors in Pseudomonas aeruginosa

Project Summary
To survive in the harsh environment of the human host, pathogens such as the gram-negative bacterium
Pseudomonas aeruginosa (Pa) must utilize a broad array of virulence factors. Aberrant firing of these often
metabolically costly pathways can result in immune detection or out competition, thus their production is tightly
regulated. Recent techniques have allowed for the expanded study of small RNA (sRNA) mediated regulation in
bacteria and it is increasingly clear that these ubiquitous molecules exert important regulatory effects, even on
systems whose regulation was previously thought to be well-understood. Recently, work from the Dove lab
utilized RNA interaction by ligation and sequencing (RIL-seq) to assess the global RNA-RNA interactions
mediated by the RNA chaperone Hfq in Pa. Among this data I found an abundant uncharacterized sRNA, that
we refer to as BecO, which appears to be highly conserved in Pa. To begin understanding the pathways impacted
by this sRNA, I performed RNA-seq. Excitingly, my preliminary data shows that BecO significantly regulates the
expression of hundreds of genes. Among these genes, those encoding for the Type III secretion system (T3SS)
and pyochelin synthesis appeared to be strongly regulated. These pathways are both critical for the virulence of
Pa, suggesting an important role for BecO during infection. Here I propose to investigate the outsized regulatory
role of this sRNA and build a skillset that can be broadly applied to investigating other sRNA regulatory systems.
This will be aided by my sponsor, Dr. Simon Dove’s expertise on sRNA regulation in Pa. In Aim 1 I will determine
how BecO controls T3SS gene expression. I will investigate whether BecO exerts its regulatory effects by base-
pairing with the mRNA transcripts of one or more of the master transcription regulators that govern T3SS gene
expression. I will also determine which of the three putative seed regions that I have identified in BecO are
involved in mediating T3SS control. In Aim 2 I propose to determine how BecO controls expression of the
pyochelin biosynthesis genes. To do this I propose to develop a more sensitive assay based on RIL-seq to
identify additional RNA interaction partners for BecO. This technique would have broad utility in the identification
of regulatory targets for sRNAs in Pa and other bacteria. Preliminary experiments have shown the growth of the
human pathogen Acinetobacter baumannii is altered when co-cultured with Pa in a manner that is influenced by
BecO. In Aim 2, I also plan to determine if this altered growth is due to any positive regulatory effects BecO might
have on pyochelin production. Together the work proposed will further our understanding of the complex
regulation imposed on P. aeruginosa virulence factors and generate new insights into how sRNAs fit into these
regulatory circuits. By performing this work in the highly collaborative and intellectually stimulating environment
of the Boston Children’s Hospital and Harvard Medical School communities I will have an excellent opportunity
to develop the skills needed to become an independent investigator.

Public health relevance
Project Narrative This study seeks to characterize novel regulatory networks in the human pathogen Pseudomonas aeruginosa, potentially providing insight into the development of therapeutics. I will specifically investigate how an abundant, previously uncharacterized, small RNA we refer to as BecO controls the production of virulence factors in P. aeruginosa and in doing so develop new tools to increase the resolution of future sRNA studies.